IMAT-ITCR Collaboration: An integrated experimental and computational platform for analyzing the spatial organization of tumor clones

Cancer genomes evolve by acquiring a diverse repertoire of DNA mutations, copy number
aberrations (CNAs), and large chromosomal rearrangements, giving rise to genetically diverse
clonal lineages. Decoupling and quantifying genetic heterogeneity and spatial cues within a
tumor is critical for understanding the basis for tumor progression and response to therapies.
The goals of PI Chen’s IMAT project are to develop Slide-seq into a high-resolution spatial
genomics platform for cancer precision medicine. This project seeks to develop robust
protocols, pipelines and computational algorithms to democratize spatial transcriptomic profiling
for clinical specimens and demonstrate them across tumor types, working directly in the clinical
setting. The goals of PI Raphael’s ITCR project are to develop a comprehensive, user-friendly,
and modular software suite for tumor heterogeneity and clonal evolution studies across space,
time, and genomic scale using data from both bulk and single-cell sequencing technologies.
Here, we seek to merge we will develop an integrated experimental and computational
platform to analyze the spatial organization of clones in tumor samples. This platform will
combine the Slide-RNA-SeqV2 and Slide-DNA-seq technologies under development in PI
Chen’s IMAT project with customized computational algorithms that extend methods developed
in PI Raphael’s ITCR project.

Public health relevance
Project Narrative Cells are the unit building blocks of tissues and organs, thus, to understand how tumors progress and develop in tissues and organs, it is important to understand where different types of healthy and tumor cells reside in the tissue. Here, we are developing new technologies that allows clinical scientists to simultaneously look at who cells are, via the genes they express, and where they reside across many different tumor types.